EVALUATION OF GANCICLOVIR IN SYMPTOMATIC CONGENITAL CMV INFECTIONS

The objective of this project is to determine the safety, tolerance, and efficacious dosage of ganciclovir for administration to infants with congenital CMV disease in Phase I and Phase II trials.